Short-Range Spread of Cytokines: Generality, Dynamics, and Impact on Population Variability

Project Summary
Immune cells produce an array of cytokines that signal the type and severity of pathogenic threats to nearby
cells, coordinating an apt immune response. The spatial reach of cytokines determines whether immune
response coordination is localized or systemic. We have previously shown that the cytokines Interleukin-2 (IL-2)
and Interferon-γ (IFNγ) spread only a few cell diameters (~4-10) from their source. Moreover, cytokine spread in
dense tissues follows diffusion-consumption dynamics, enabling precise predictions about tissue distribution,
gradient sharpness, and heterogeneous exposure among neighboring cells. Consequently, when cytokine
receptors are abundant, cytokines spatially-confine and form steep concentration gradients. These emergent
cytokine signaling niches can drive downstream gene expression heterogeneity, and functional differences
between cells. This project explores the central hypothesis that T-cell derived cytokines have limited spread,
creating transient localized signaling niches that drive cellular variability within tissues.
Although we have extensive data on the limited spatial spread of IL-2 and IFNγ, it's still uncertain if
localized signaling niches are typical for all T-cell derived cytokines. In Aim 1, we will combine in vitro cytokine
penetration assays with cyclic immunofluorescence measurements of cytokine responses around activated T
cells in lymph nodes to characterize the spatial extent of T cell derived cytokines.
Secondly, cytokine exposure can trigger cellular responses like proliferation, death, or changes in
receptor expression, dynamically influencing the range of cytokine spread. In Aim 2, we will combine spatial
modeling of cytokine spread and response, live-cell microscopy of regulatory T cells within IL-2 signaling niches
in 3D in vitro culture systems, and whole organ imaging of mouse lymph nodes to explore the dynamics of IL-2
signaling niche formation, maintenance, and resolution.
Lastly, single-cell studies reveal significant gene expression variability among cells of the same type
within the same organ. This variability is often attributed to stochastic factors or cell-intrinsic phenomena.
However, differential exposure to cytokines due to their heterogeneous spatial distribution can be a substantial
driver of population variability in gene expression. In Aim 3, we'll use a probabilistic model to link gene expression
variability in cell populations to cytokine spatial heterogeneity. Using gene expression response to IL-2 in
regulatory T cells as a test case, we will combine 3D culture experiments with in vivo experiments in mice to
quantify the degree of gene expression variability attributable to differential exposure to the cytokine.
Our research bridges detailed single-cell transcriptomics and tissue immunology, focusing on a range of
cytokines to understand their spread and impact on immune responses in dense organ environments.
Leveraging biophysical theory, advanced 3D cell cultures, in vivo mouse models, and mathematical modeling,
we're uniquely positioned to answer these fundamental questions about cytokine-driven immune dynamics.

Public health relevance
Project Narrative This project aims to quantify the spatial reach of T cell derived cytokines such as IL-2, IFN-γ, and TNF within the dense cellular landscapes of immune tissues and to determine how their spatial heterogeneity contributes to the variability in immune cell behavior. The research will provide concrete measurements of cytokine spread and its effects on cellular communication between white blood cells, offering a clearer picture of how immune responses are spatially organized at the tissue level.